ShEEP Request for Particle Matrix ZetaView

Extracellular vesicle (EV) research is a fast-moving area of research. Biological nanoparticles
such as EVs, exosomes, viruses, lipids are part of normal homeostasis and now we believe a
major part of pathological conditions. The San Francisco VA was the first in the UCSF community
to purchase a NanoSight nanoparticle tracking system, 8 years ago. The field has moved very
quickly and the new Particle Matrix ZetaView, we believe has replaced the NanoSight technology.
The ZetaView can rapidly characterize particles as to size, particle concentration and surface
charge. It also has the advantage of characterizing particles by fluorescent labelling without any
additives and with a very small sample. The ZetaView has 4 lasers to enable the user to use
different dyes to discriminate different particles and allows the user to quantify colocalization ratios
of biomarkers. This nanoparticle tracking analysis is rapid and user friendly. This basic
characterization of EV particles is essential in any project to use EVs as biomarkers and
treatments. This new machine will attract new users to the field of EVS and facilitate current users
for their funded projects.

Public health relevance
The long-term objective of this application is to continue to do cutting edge research in extracellular vesicles (EVs) that will lead to biomarkers for disease processes and treatments for diseases that affect Veterans’ health. Current and future funded applications will need a state-of- the-art method to enumerate EVs, determine particle size, differentiate 4 targets and determine surface charge. Current studies using EVs include HIV and postCOVID, TBI, frontotemporal dementia (FTD), amyotrophic lateral sclerosis (ALS) and inflammation associated with cardiovascular disease and diabetes. In addition, this new technology can measure viruses. This technique is rapid and user friendly. We are requesting this Particle Matrix Quatt-4 to replace an 8-year-old NanoSight Tracking machine. Our long-term goal is to provide our VA research community with the latest nanoparticle tracking analysis.